Bridging gap in comparative biology using the tree shrew visual system

PROJECT SUMMARY
A major dichotomy in comparative biology is the divergence of visual specializations in different species.
This is prominently observed in rodents and primates - the former specialized to detect movement in low light
conditions while the latter specialized to detect fine spatial patterns and color. A large body of research on
these visual systems points to fundamental differences in structural, functional and genetic makeup of neural
circuits in the early visual pathway. This makes it difficult to understand how different features of the visual
world are selectively processed in the retina and in the brain. Achieving a comprehensive understanding of
higher visual processing requires an understanding of visual processing in not just rodents and primates but
also in other species. This also calls for the use of novel technologies for probing and translating findings
across different visual systems. Tree shrew is a small animal at the phylogenetic midpoint of rodents and
primates, with highly developed retina and visual cortex. Because of their diurnal and excellent color vision,
tree shrews have been extensively used as a model system for understanding color processing in the
mammalian visual system. This proposal will combine advanced techniques such as large-scale
measurements of neural population activity, genetic screening and viral tracing to achieve detailed functional
characterization of retinal ganglion cells and their connectivity to the LGN. In aim 1, we will use a high-density
multi-electrode array for recording activity of large populations of retinal ganglion cells (RGCs), to reveal how
morphologically and functionally distinct RGC types encode distinct visual features in their responses. To
determine the diversity of gene expression in functionally distinct RGCs, in aim 2, we will employ high-
throughput single-cell RNA sequencing of RGCs. We will also test for the presence of well-established
molecular markers for RGC types, in the tree shrew retina. Finally, in aim 3, we will use viral labeling to
determine the precise pattern of convergence from the retina to the LGN. By measuring the response of
optogenetically stimulated RGCs, we will establish the lamina specific LGN projections of functionally distinct
RGC types. These experiments will provide a comprehensive understanding of the structure and function of
neural circuits in the early visual pathway, that produce distinct visual specializations in different species. This
study will establish tree shrew as a model system for comparative studies on visual processing in higher
mammals and provide novel insights into the pathologies of vision.

Public health relevance
PROJECT NARRATIVE While rodents and primates have been extensively used as model systems for studying visual processing, a major dichotomy remains that their visual systems are optimized to perform different tasks, such as detecting movement versus detecting fine special pattern. Tree shrew lies phylogenetically between rodents and primates, and has a sophisticated chromatic visual system that is similar to primates; thus lending itself as an ideal model system to resolve this dichotomy and identify cell types and genes involved in retinal pathologies. The proposed studies will establish tree shrew as a model system for studying how visual signals are processed in distinct retinal circuits and routed to higher brain areas, producing distinct visual specializations in different species.